Optimizing ablation of cervical precancer with ethyl cellulose ethanol to enable translation to women in low and middle-income countries

Abstract
Cervical cancer affects the lives of half a million women worldwide each year, and over half of these women die.
Preventative solutions that are widely used in wealthy countries are not practical for use in medically underserved
regions due to sophisticated technologies and expertise needed to sustain these solutions. Thus, alternative
protocols that employ low-cost, simple-to-use technologies are needed to prevent cervical cancer. Our vision is
to develop high quality, low-cost interventions that will be effective in low and middle-income countries (LMICs)
to address shortcomings of current solutions for cervical cancer prevention. The Calla Health Foundation is
developing the tools needed to help meet the WHO metrics for cervical cancer elimination in the next 100 years.
Under fast track SBIR funding (R44CA240019), we are developing tools for point-of-care screening and
diagnosis. However, screening and diagnosis alone will not lead to decreases in cervical cancer mortality if
access to point-of-care treatment remains limited. While Loop Electrosurgical Excision procedure (LEEP) is the
most widely used treatment in high-income settings, cryotherapy is more commonly used in LMICs. Recently,
thermocoagulation has gained acceptance for ablation of cervical pre-cancer as it does not require consumables
(continuous supply of pressurized liquid nitrogen for cryotherapy) or a stable power supply (for LEEP). However,
thermocoagulation is limited by bioheat transfer and therefore the depth of necrosis it can achieve. To develop
a complementary therapeutic approach to thermocoagulation, the goal of our Phase I SBIR grant was to establish
an injectable low-cost ablative therapy based on controlled delivery of a ubiquitous agent, ethanol to treat cervical
pre-cancer. Specifically, we developed a new formulation of ethanol using a polymer called ethyl cellulose (EC)
to act as a slow-release gel limiting off target toxicity and an automated injector to reliably deliver ethanol into
the region of interest. Moving forward, the goal of our Phase II SBIR grant is to develop beta versions of the
automated injector, develop packaging and quality control metrics for EC-ethanol, and assess if a combinatorial
therapy in which sequential EC-ethanol ablation and thermocoagulation are applied to the cervix is synergistic
and enhances efficacy. This work will include the following specific aims: 1) evaluate usability and repeatability
of hand-held injectors for EC-ethanol delivery; 2) establish EC-ethanol stability and potency testing plan and
release criteria; 3) assess safety and efficacy of sequential EC-ethanol ablation and thermocoagulation
compared to monotherapies; and 4) assess clinical workflow and population health impact of monotherapies and
combinatorial therapy.

Public health relevance
Project Narrative The goal of this SBIR is for PIs from academic and small business institutions to work in partnership to develop a technological strategy that will transform treatment of cervical pre-cancer in low-income communities. The proposed research is significantly relevant to public health, as the developed technologies will contribute to the improvement of cervical cancer prevention, and thus a reduction in the mortality rate of this imminently preventable disease.